Roswell Park CCSG Admin Supplement: Close out EDDOP Studies

Roswell Park Comprehensive Cancer Center (Roswell Park), established in 1898 is one of a small number of
freestanding, NCI-designated, comprehensive cancer centers and the only comprehensive center in New York
State (NYS) outside of Manhattan. The sole mission of the Center is to eliminate cancer's grip on humanity
through cancer research, treatment, prevention and education. The Cancer Center which is in its 46th year
of funding, is currently organized around 4 research programs, 9 shared resources, a clinical trial infrastructure
that prioritizes investigator-initiated and innovative clinical trials that are a product of the research programs and
a community outreach and engagement (COE), Cancer Research Training & Education Coordination (CRTEC)
and Plan to Enhance Diversity (PED) that are interactive, cross-functioning and responsive to our catchment
area. The Cancer Center supports 145 members and has recruited 162 new faculty since the previous review
with 42 of them new members of the CCSG. Our cancer-relevant direct grant funding is currently $79M with 49%
($39M) coming from the NCI, a more than doubling of our NCI funding from 2018 with over 56% of funding in
program/multi-PI type grants that underscores our commitment to collaborative research. Our high impact
papers have increased to 29% from 10% in 2018 resulting in practice, paradigm and policy changing research.
We have increased our focus on our community outreach and engagement, and we have an enhanced approach
to our community and catchment area needs, especially with regard to diversity equity and inclusion. The
Specific Aims over the next 5 years are as follows: Aim 1: Innovation: To be a leader in the development of
innovative approaches in cancer research across basic, clinical and population sciences to improve the quality
of care for our patients in our catchment area and beyond. Aim 2: Translation: To enhance collaborative efforts
between basic, clinical and population scientists toward the more effective translation of our discoveries into
paradigm changing patient practices and interventions and policies. Aim 3: Education: To train and develop
the next generation of scientists and physicians through innovative oncology-focused programs that continue to
develop translational opportunities across the clinic, the basic science and population science areas. Aim 4:
Community: To ensure that the needs and priorities of communities in our catchment area are catalyzing high-
impact science with a specific focus on strategies to promote health equity and drive rapid translation of scientific
advances to reduce the cancer burden and related disparities in our catchment area and beyond. Aim 5: Equity
& Inclusion: To cultivate, value and support diversity, equity, inclusion and belonging across our cancer center
employees, scientists, physicians, nurses and healthcare staff, students and trainees and leadership toward a
more productive and diverse workplace and to serve our community more effectively. Roswell Park continues to
play a primary role in discovery and innovation in basic science findings that enable us to deliver the best cancer
care to our patients in New York State, around the country and around the world.

Public health relevance
PROJECT NARRATIVE Roswell Park Comprehensive Cancer Center (Roswell Park) will complete all necessary task related to the compliant close out of 5 remaining studies. This process will facilitate the IRB closure / termination of the studies along with transitioning all patients to off study status in compliance with the NCI’s completion of the program. Funds will be used to support data management and study coordination during the closeout of the ETCTN trials.